Development of Host- Oriented Therapeutics Targeting Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2),

The ultimate goal of this Phase I application is to discover and develop host-oriented small molecule compounds
targeting Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) infection. SARS-CoV-2 is a novel
coronavirus driving the current global pandemic of severe respiratory syndrome in humans. Antiviral therapeutics
are urgently needed to combat infection by SARS-CoV-2 and new variants that are continuing to emerge. We
have discovered several chemical series that target modular interactions between specific host proteins
containing WW-domains (e.g. Nedd4) and viral proteins containing PPxY motifs (e.g. Ebola VP40). Notably,
emerging RNA virus pathogens such as Ebola, Marburg, Lassa, and rabies viruses all encode PPxY motifs that
recruit host WW-domain containing proteins to facilitate efficient virus egress, spread, and transmission.
Interestingly, the surface-exposed Spike glycoprotein (S) of SARS-CoV-2 also has a putative WW-domain
binding motif (25PPAY28), that is not present in the S protein of SARS-CoV-1 or more attenuated coronavirus
strains. The acquisition of this PPAY motif in the major surface protein of SARS-CoV-2 virions raises the
intriguing possibility that it may contribute to the unique pathogenicity and/or transmission of SARS-CoV-2 via
interactions with specific host WW-domain bearing proteins. In our ongoing studies on filoviruses and
arenaviruses, we have used extensive SAR to identify a lead compound series capable of blocking egress and
spread of live EBOV, MARV, and LAFV in cell culture, as well as blocking disease progression in vivo in a live
MARV challenge model. Here, we hypothesize that “informed” SAR analyses of our in-hand PPxY/WW-domain
inhibitors (e.g. lead candidate FC-10696) will lead to the discovery of analogs capable of blocking egress and
disease progression of SARS-CoV-2, as well as related PPxY-containing variants that may emerge in the future.
In support of our hypothesis, we present strong preliminary data showing that the PPxY motif within the S protein
of SARS-CoV-2 virus can interact with host WW-domain containing proteins that are known to promote egress
and spread of EBOV, MARV, and LAFV. Moreover, our current lead candidate PPxY budding inhibitors show
activity in blocking egress of live SARS-CoV-2 virus infection in human lung epithelial cells. In this Phase I
proposal, we will identify and evaluate host-oriented inhibitors as potential therapeutics for SARS-CoV-2 and
related coronaviruses by combining the pharmaceutical and medicinal chemistry expertise of the scientists at
the Fox Chase Chemical Diversity Center, Inc. (FCCDC) with the expertise and experience of the Harty Lab at
the University of Pennsylvania in the experimental aspects of virus-host interactions and antiviral therapy, and
the lab of Olena Shtanko at Texas Biomedical Research Institute for evaluating compounds against live viruses
under BSL-3 conditions. The three aims are (1) lead finding and optimization medicinal chemistry including
ADME profiling, (2) evaluation for the ability to specifically inhibit egress of SARS-CoV-2 VLPs and PPxY-
mediated S-host protein interactions, and (3) in vitro and in vivo analyses against authentic SARS-CoV-2 virus.

Public health relevance
There is an urgent need to develop antiviral therapies against Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) and its emerging variants such as Omicron. We have been successful in discovering small molecule compounds that disrupt budding and spread of emerging RNA viruses including Ebola, Marburg, and Lassa fever viruses; a process that is critical for virus dissemination and disease progression. Here, we will use our established expertise in medicinal chemistry and virus budding assays to adapt and develop these host-oriented, antiviral budding inhibitors to target SARS-CoV-2 virus egress and transmission.